Alcohol Use Disorder Treatment Simulation: Modeling treatment impacts on alcohol-related disparities

Excessive drinking results in tremendous economic and social costs and is a leading
cause of preventable death in the US. Relatively few people with alcohol use disorder
(AUD) receive appropriate services, and there are wide subgroup differences in access
to alcohol health services. The proposed study will answer pressing questions about
how to improve access, using simulation modeling to examine whether universal
increases in access to evidence-based practices (EBPs) such as screening, brief
intervention, and referral to treatment (SBIRT) or medication-assisted treatment are
sufficient, or whether more targeted efforts also are needed to reach certain population
subgroups. Simulation models are well-suited for identifying unintended consequences
of interventions implemented in complex systems, as well as outcomes that may occur
years after implementation. By projecting intervention effects across population
subgroups over time, simulation modeling can help identify and prioritize types of alcohol
health services interventions to increase access to care. Although simulation methods
are being used to address the opioid crisis, to date there is no published simulation
model comprehensively describing the continuum of alcohol health services in relation to
AUD. The proposed study fills this gap by simulating effects of increased access to
alcohol health services across the continuum of care from SBIRT, to specialty care
(including AUD medications) and informal treatment (including 12-step groups like
Alcoholics Anonymous). First, we will build and calibrate a microsimulation model of
alcohol health services for people with mild, moderate, and severe AUD, guided by a
conceptual model that includes factors that impact access to treatment at the individual,
organizational, community, and policy levels. Next, we will use a geographically situated
simulated population representing the large, demographically, and geographically varied
states of California and Texas to make long-term projections for AUD severity and
recovery for key population subgroups over time. Finally, informed by theories of
healthcare access and utilization, we will project changes in AUD treatment receipt
under several enhanced conditions to identify the mix and distribution of services that
would best increase access to care, and we estimate costs and benefits of improved
service access. Study Aims are to assess effects of (1) universal implementation of
EBPs in traditional and non-traditional settings and (2) improving accessibility,
availability, affordability, and acceptability of alcohol health services, and to (3) estimate
cost and cost-effectiveness of these changes. Results will provide detailed information to
inform service planning by states, counties, and communities to improve health services,
including projections for how and where to intervene in a cost-effective manner to reduce
the burden of AUD and increase long-term recovery for vulnerable populations.

Public health relevance
Heavy drinking is a leading cause of preventable death, and untreated alcohol use disorder (AUD) has economic and social costs that are due in part to gaps in access to alcohol health services. This study will use existing survey and administrative data to simulate multiple, simultaneous improvements in access to care across the continuum from screening for unhealthy drinking to treatment and recovery support to model longterm impacts on recovery from AUD. We expect study results to help inform efforts of clinicians, treatment providers, and policymakers to improve access to care to maximize the benefits within local cost constraints.